2022 Sensory Transduction in Microorganisms GRC & GRS

Project summary
The 2022 Gordon Research Conference on Sensory Transduction in Microorganisms to be held in Ventura CA
in January 2022 will explore recent advances in understanding signal transduction in bacteria, especially
pathogens. Focus will be placed on chemosensory mechanisms and pathways, small molecule intracellular
signals (e.g. c-di-GMP), two component systems and the cellular processes they regulate as well as
mechanisms of bacterial lifestyle decisions including biofilms, bacterial multicellular behavior and predator-prey
interactions. The roles of these systems with respect to pathogenesis, antimicrobial resistance, and synthetic
biology will be central themes. An important topic for this conference will be host-microbe interactions. All these
critical areas will be addressed through cutting-edge applications of molecular genetics, cell biology,
biochemistry, and chemical biology as well as structural, imaging, biophysical, and computational approaches.
Data from high-resolution experiments will be paired with modeling to understand and predict the behavior of
complex macromolecular assemblies and signaling circuitry. Invited speakers will include both established and
early-stage investigators using a wide array of approaches. In addition, short talks will be chosen from the
abstracts to give additional early-career scientists a chance to speak, and to round on the program.
Participants will benefit from the Conference's open, collegial atmosphere that provides multiple opportunities
to engage in scientific discussion, promote scientific rigor, and foster interdisciplinary collaboration. New,
innovative efforts will be used to increase participation of scientists from historically under-represented
backgrounds, and multiple efforts will be taken to make participants feel welcome and valued. For the fifth time,
a Gordon Research Seminar (GRS) for postdocs and graduate students will precede the GRC. The GRS
provides a supportive environment for young scientists to present their work, make connections, and receive
advice by leaders in the field. The STIM community has long supported junior scientists, and we view the
success of the GRS as a necessity to continue on this mission. The GRS will help us not only nurture the
development of early stage investigators, but also promote diversity within our community. The GRS will help
junior scientists gain the confidence and skills to become full-fledged GRC participants. The well-integrated
STIM GRC/GRS will direct established investigators to the most important questions confronting our field and
will encourage young scientists to apply their recent training to the exciting new areas of microbiology.

Public health relevance
Narrative Sensory and signal transduction processes are essential for bacterial pathogens to produce virulence factors, to resist antimicrobials, to invade host tissues, and to evade the immune system. The 2022 STIM GRC will gather researchers from diverse fields to understand how bacteria sense and respond to their environment at levels that range from molecular mechanisms to interactions with the host on organismal level. The meeting will provide a powerful collaborative platform to address these questions from different perspectives, which will inform new strategies to develop antimicrobials and to combat infectious diseases.